Role of Mast cells in regulating inflammatory pathology of secondary lymphedema

PROJECT SUMMARY/ABSTRACT
Secondary lymphedema is a chronic, debilitating condition that commonly occurs due to infections or to
injury to the lymphatic system in patients who undergo surgical resection of the tumor, lymph node dissection,
radiation, or chemotherapy for breast or other solid tumors. This condition is characterized by tissue swelling,
recurrent infections, and diminished quality of life. Currently, there is no drug FDA-approved specifically for
treating lymphedema, and existing therapies are primarily palliative, focused on symptom management rather
than a cure. Thus, there is an urgent need to better understand the underlying pathology of lymphedema and
develop novel treatments.
Recent studies have highlighted the crucial role of Th2-differentiated CD4+ T cell adaptive immune
responses in lymphedema pathology, which exacerbate lymphatic damage, slow down lymphatic regeneration,
and contribute to fibroadipose tissue deposition, as well as the key role of keratinocytes in CD4+ T cell pathology.
However, the cellular mechanisms that activate T cell adaptive immune responses following lymphatic injury
remains unknown. Interestingly, our preliminary studies suggest that mast cells, an innate immune cell type, may
play an important role in T cell activation and lymphedema pathology. Using patient biopsies and mouse models,
we observed a significantly increased presence of mast cells in lymphedema tissues, along with elevated
expression of mast cell activator proteins (IL-33, stem cell factor [SCF], and thymic stromal lymphopoietin [TSLP])
on keratinocytes following lymphatic injury. We also identified mast cells as a major source of Th2 cytokines IL-
4 / IL-13 in lymphedema biopsies; neutralizing these cytokines reduced mast cell numbers in our pilot clinical
trial. Building on our preliminary work and considering the role of mast cells in the pathophysiology of other skin
and fibrotic disorders, such as atopic dermatitis, we hypothesize that lymphatic injury induces the expression of
mast cell activators and Th2-inducing proteins (IL-33, SCF, and TSLP) by keratinocytes. These activators
facilitate the recruitment and activation of mast cells, thereby amplifying CD4+ Th2 inflammatory responses in
lymphedema. Our proposed study is novel because the role of mast cells in lymphedema has not been studied.
To address this important gap in our knowledge of lymphedema pathology, we will test our hypothesis by
investigating how mast cells are recruited and activated in lymphedema following lymphatic injury using patient
tissues and animal models. We will perform spatiotemporal and single-cell RNA sequencing analyses, and we
will explore the roles of lymph fluid and keratinocytes on mast cell activation. We will also use knockout and
transgenic mice models to analyze how mast cell-derived Th2 cytokines (IL-4 / 13) contribute to Th2
differentiation of CD4+ T cells and overall lymphedema pathology.

Public health relevance
PROJECT NARRATIVE/RELEVANCE Secondary lymphedema, a chronic and debilitating complication resulting from infections or cancer treatment, lacks a definitive cure. To address this challenge and develop effective treatments, it is crucial to bridge gaps in our knowledge of its pathophysiology. This project will shed light on how innate immune responses mediated by mast cells initiate and coordinate T cell inflammation, a pivotal factor in lymphedema pathology.